What does it really mean to be broad? Uncovering underlying biology behind broadly neutralizing antibodies

The importance of antibodies in preventing and controlling human disease cannot be
underestimated. Many vaccines depend on neutralizing antibodies for protection. In addition,
neutralizing antibodies are highly useful when administered therapeutically. The ongoing pandemic
has brought to light that few therapeutic antibodies can stand the test of time as new viral variants
emerge. The promise of broadly neutralizing antibodies, which recognize conserved epitopes shared
across entire groups of related pathogens, is that they are evolution-proof and remain protective in the
face of pathogen evolution. Yet, as evidenced by clinical data, there are few examples where such
antibodies cannot be escaped. This led me to wonder, what properties truly define what it is to be
broadly neutralizing? Irrespective of the pathogen, broadly neutralizing antibodies are almost always
very rare. In any given study, one might screen thousands of antigen-specific B cells to find a single
broadly neutralizing antibody. Therefore, this rarity may explain some crucial underlying biology.
Perhaps, these neutralizing antibodies are only broad because they are rare. In other words, pathogens
are under little selective pressure to escape antibodies that are infrequently made. This leads to my
central hypothesis that most broadly neutralizing antibodies are broad because they are rare, not
because they target conserved epitopes that cannot mutate without a fitness cost to the pathogen.
Using SARS-CoV-2 as a model pathogen, I will test these concepts. In Aim 1, I will determine whether
infrequency is a defining feature of broadly neutralizing antibodies. In Aim 2, I will determine whether
some epitopes, are more difficult to evolve away from than others. The results of this work will provide
a deeper understanding of the relationship between antibody epitopes and resistance to viral escape.
The methods developed in this project have applications far beyond SARS-CoV-2. In addition, this
approach may provide a more efficient way for researchers to screen large amounts of sequencing
data to identify potentially broadly neutralizing antibodies.

Public health relevance
Project Narrative: Neutralizing antibodies that prevent and control human disease are of considerable therapeutic value, yet the ongoing pandemic has brought to light that few therapeutic antibodies can stand the test of time as new viral variants emerge. In this proposal, I will test fundamental mechanisms as to why this happens and create new strategies to rapidly identify more antibodies with therapeutic potential.